Administrative Core (Core A)

PROJECT SUMMARY/ABSTRACT – Core A, Administrative Core
The Administrative Core is responsible for the overall management and coordination of the Center of Excellence
for Translational Research (CETR) for “Advancement of Vaccines and Treatments for Ebola and Marburg Virus
Infections”. It provides governance, financial oversight, and operational management functions to facilitate the
execution of the overall research plan, thereby enabling the CETR to fulfill its mission to develop postexposure
treatments for Ebola and Marburg hemorrhagic fever. The Administrative Core will provide an organizational and
programmatic structure to promote research productivity and synergy through scientific interactions. The Core
will provide oversight in setting CETR priorities, including decision-making processes involving the continual
evaluation of research and product development. Core personnel will ensure that the CETR is compliant with
issues involving the use of vertebrate animals and human subjects, and ensure that regulatory expertise is
available for associated translational activities. Management activities are carried out with the advice of the
Scientific Advisory Committee in close collaboration with NIAID’s biodefense program administrators.
Teleconferencing is maximally utilized to facilitate communication between the University of Texas Medical
Branch, the lead institution for the CETR, and other participating institutions.